Inhibitory Network Plasticity in Neurological Disease

Project Summary: Temporal lobe epilepsy (TLE) develops in a third of over 300,000 patients and lead to long
term memory and cognitive disorders which impact quality of life. The dentate gyrus, a circuit severely
impacted in hippocampal sclerosis in TLE, serves as the first node in the flow of cortical information to the
hippocampus. The dentate gyrus is a critical for episodic memory function and is proposed to discriminate
highly similar inputs through a process known as pattern separation, the underlying mechanisms of which are
not fully understood. The dentate receives highly structured inputs with lateral entorhinal cortical projections
with content or object related information targeting the distal dendrites of the granule cells through the lateral
perforant path and spatial and contextual information from the medial entorhinal cortex reaching the middle
dendrites through the medial perforant path. However, the circuit mechanisms underlying how these inputs
streams are processed to discriminate subtle differences in each modality, how they are associated to form
episodic memory representations and their contribution to dentate electrical activity patterns associated
memory consolidation and recall are not known. We propose that input specific recruitment of inhibitory
neurons and their layer specific inhibition of granule cell dendrites is critical for the ability of the dentate to
decorrelate distinct input streams. Since dendrite targeting dentate interneuron subtypes undergo extensive
structural and functional plasticity in epilepsy, we further propose that seizure induced changes in dendritic
inhibition compromise input specific recruitment of inhibition and undermine input output transformations.
Combining electro- and optophysiology in ex vivo slices from transgenic mice subject to experimental epilepsy
and behavioral and multisite recordings with optogenetic interrogation will allow us to address these questions.
Aim 1 will develop a fundamental understanding of input specific and recruitment, and frequency dependent
dynamics of dentate interneuron subtypes and how it is altered in epilepsy. Aim 2 will determine the role of
somatic and dendritic inhibition in dentate decorrelation of layer specific inputs and their transformations in
epilepsy at the circuit level. Finally, Aim 3 will examine determine the role of inhibitory neuron subtypes to
behavioral spatial and object discrimination and electrical correlates of dentate memory processing in control
and epileptic mice. in line with the proprieties established in the 2021 AES/NINDS Epilepsy Research
Benchmarks, these studies will address mechanisms underlying neuropsychiatric comorbidities in epilepsy and
is of broader relevance to understanding memory processing and decline in ageing and Alzheimer’s Disease.

Public health relevance
Narrative: Epilepsies contribute to over a quarter of the disability burden of neurological disorders with cognitive deficits impacting quality of life. Studies proposed here will identify fundamental mechanisms of memory processing in the hippocampal dentate gyrus, a circuit heavily impacted in temporal lobe epilepsies, and how they are altered by adaptive and maladaptive circuit changes in epilepsy. The studies will address key knowledge gaps relevant to the 2021 AES/NINDS Epilepsy Research Benchmarks priority area of understanding mechanisms of neuropsychiatric comorbidities in epilepsy and have broader relevance to mechanisms of memory decline in ageing and neurodegenerative disorders like Alzheimer’s Disease.